Molecular mechanisms driving the coevolution of clinical isolates of phages and epidemic Vibrio cholerae

Illness and death caused by infectious diarrheal disease agents, like Vibrio cholerae, are major threats to
public health and significant barriers to socioeconomic development worldwide. Natural disasters and
continuing conflict in some depressed regions threaten to exacerbate the already rising incidence of cholera
globally. Comparative genomics of V. cholerae isolated over the last century reveal recurring episodes of novel
genetic variants with new repertoires of mobile genetic elements (MGEs) spreading globally from where they
initially emerged in the Bay of Bengal. For unknown reasons, a hallmark of this pattern is that previously
prevalent strains completely disappear when new variants emerge. The arms race between viruses and their
host organisms is a key driving force in the evolution of all cellular life. Successful strains of epidemic V.
cholerae must defend against the ubiquitous threat of predatory phages in aquatic reservoirs and the intestinal
tract during human disease. In collaboration with the icddr,b, we have established a longitudinal collection of
clinical phages and V. cholerae isolates to serve as a tractable, clinically relevant platform to study
mechanisms driving reciprocal adaptations in ongoing phage-bacterial conflict. Using this platform, we
discovered fluctuating MGEs in epidemic V. cholerae that provide robust protection against co-circulating
phages. One such family of anti-phage MGEs, called PLEs, provides exquisitely specific protection against
ICP1, the predominant phage in cholera patient stool samples. We discovered novel mechanisms that ICP1
evolved to counter PLEs and other V. cholerae defenses. Although we have made critical advances in
understanding mechanisms underpinning reciprocal adaptations that contribute to some of the observed
diversification and dynamics of PLEs and ICP1 in nature, many observations from our extensive collection of
contemporary clinical isolates remain unexplained. To reveal molecular mechanisms contributing to the
selection of emergent phage and epidemic V. cholerae genotypes, we will pursue the following specific aims:
1) We will examine how a novel PLE variant blocks phage despite phage-mediated degradation of PLE. 2) We
will interrogate barriers limiting the acquisition and maintenance of co-resident PLEs in V. cholerae, and 3) We
will define the array of defenses and counter-defenses in a clinical collection of V. cholerae and phage. The
proposed studies will advance the understanding of factors influencing population shifts in epidemic V.
cholerae and reveal novel mechanisms underpinning phage-bacterial coevolution. This knowledge will further
enhance our understanding of phage-mediated perturbations to microbial populations in healthy and diseased
states and advance our capacity to manipulate these communities for therapeutic or prophylactic benefit.

Public health relevance
PROJECT NARRATIVE The arms race between viruses and their host organisms is a key driving force shaping the evolution of all forms of life. This proposal aims to determine the molecular mechanisms driving reciprocal adaptations between bacteriophages and phage-defense elements in Vibrio cholerae, the causative agent of the severe diarrheal disease cholera. This study will advance our understanding of the factors promoting the evolution of epidemic V. cholerae and help to inform infection control measures for antibiotic-resistant bacterial pathogens.